The role of ciliary melanin-concentrating hormone receptors in Alzheimer's disease

Project Abstract
Primary cilia are cellular organelles with sensory functions. Ciliopathy is defined as a disease associated with
abnormal cilia function or structure. Ciliopathies are associated with expanding spectrum of kidney, liver, and
cardiovascular disorders. However, it is yet to be investigated whether or not Alzheimer’s disease (AD) is
associated with cilia function and structure. In this Administrative Supplement proposal, we combine expertise
from two laboratories of the neighboring institutions. This multi-PI proposal includes Dr. Surya Nauli (Chapman
University), whose laboratory has strong records in interrogating primary cilia functions, and Dr. Amal Alachkar
(the University of California, Irvine), whose research group has strong expertise in neurological degeneration of
AD. The overall goal of this proposal is to examine the alterations of cilia structure and functions in early- and
late-stage AD mouse brains. It is known that melanin concentrating hormone receptor (MCHR1) is localized in
cilia of neuronal cells within the frontal cortex and hippocampus. In Aim 1, we will investigate if the deletion of
MCHR1-expressing cilia exacerbates cognitive deficits in 5xFAD mouse model of AD. We will use both cilia and
AD mouse models to study behavioral and memory changes in these mice. In Aim 2, we examine if selective
pharmacological targeting of ciliary MCHR1 improve cognitive deficits in AD. We will apply nanoparticle-
targeting, which is part of the parental grant to evaluate if ciliary MCHR1-targeted therapy improves the
behavioral deficits in 5xFAD-AD mice. The outcomes of these limited studies offer new knowledge if MCHR1-
expressed cilia (Aim 1) and ciliary MCHR1 (Aim 2) are involved in behavioral deficits in AD mice.

Public health relevance
Project Narrative In this Administrative Supplement, we will look at the roles of primary cilia in Alzheimer’s disease (AD). We will analyze the roles of cilia in behavioral deficits and dementias by introducing a potential targeted therapy in our AD and cilia mouse models.